Center for SOcial CApital (SOCA): Promoting Multigenerational Health

The overarching mission of the Center for Social Capital (SoCa) is to bring together academic institutions,
community-based organizations, and a diverse group of stakeholders to reduce cancer health inequities due to
persistent poverty. New York City (NYC) is a region of extremes with some of the richest and poorest living in
close proximity. These extremes have profound impact on health with major inequities in life expectancy with
cancer driving these differences as the number 1 and 2 cause of premature mortality and overall mortality,
respectively. NYC is one of the most diverse in the U.S., with approximately 2/3 non-White, 1/3 foreign-born,
and at least 1/5 living below the Federal poverty line across four counties with persistent poverty. With such
diversity, come challenges with respect to implementing cancer control programs to meet the needs of all.
Using a community-engaged approach, we identified the top three social determinants that exerted the
greatest barriers to early detection and treatment of cancer in communities of persistent poverty were; 1)
financial burden; 2) low health literacy, and 3) community/ social context (i.e., lack of social support/cohesion,
stigma, discrimination).
NYC has a long history of migration and immigration, which has resulted in racially/ethnically
segregated communities. Residential segregation concentrates disadvantages in minority communities by
limiting social, economic, and educational opportunities and resources while concentrating poverty in these
communities. However, for some segments of the population, especially new immigrants, residing in a highly
segregated community has positive health effects through co-ethnic social support networks also known as
“ethnic enclaves” and resource availability. Hence the constructs of social capital and social cohesion may play
a significant role in mediating the relationship between residential segregation and negative health outcomes,
such as cancer incidence and mortality. Our mission as a Center is to reduce cancer health inequities in
persistent poverty census tracts throughout NYC by promoting multi-generational health. Specifically, we aim
to: Develop a rich interdisciplinary, and collaborative partnership with community organizations that will infuse
stakeholder-engaged research methods and will build sustainable approaches for cancer control (Aim 1);
Conduct two complementary projects that focus on novel interventions in persistent poverty communities
aimed at two structural determinants of health—education and health care—in which the interventions aim to
increase social capital among youth in school settings, and patient navigators in Federally Qualified Health
Centers as a means to alleviate systemic inequities (Aim 2); and leverage capacity across four geographically
separate groups of persistent poverty census tracts in NYC to cultivate the next generation of investigators and
develop sustainable Core infrastructure to achieve cancer health equity (Aim 3).

Public health relevance
The overarching mission of the Center for Social Capital (SoCa) is to bring together academic institutions, community-based organizations, and a diverse group of stakeholders to reduce cancer health inequities due to persistent poverty in New York City (NYC) by promoting multi-generational health. We will conduct two complementary projects that focus on novel interventions in persistent poverty communities aimed at two structural determinants of health—education and health care—in which the interventions aim to increase social capital among youth in school settings, and patient navigators in Federally Qualified Health Centers as a means to alleviate systemic inequities The SoCa Center will leverage capacity across geographically separate groups of persistent poverty census tracts in NYC to cultivate the next generation of investigators and develop sustainable Core infrastructure to achieve cancer health equity.